Administration and Clinical Regulatory Affairs

The functions of Core Unit A are as follows: 1) To provide all the administrative and fiscal services that are required for support of the research activities of the Projects and the Core Units; 2) To coordinate all the clinical regulatory activities of all the components of the Program Project; 3) To interact with US Federal, Greek, EU and local regulatory agencies, as required; 4) To organize all the communications between components of the Program Project; 5) To coordinate and support the activities of the Internal and External Advisory committees 6) To organize and coordinate the scholarly activities of the Program Project including biweekly teleconference-lab meetings of the Seattle-New York-Thessaloniki investigators, 7) To organize the bimonthly evaluation and planning meetings of the executive committee of the Program Project. 8) To coordinate the fulfillment by all components of the Program Project of administrative requirements concerning biosafety, animal welfare etc 9) To assist the Principal Investigator in preparation of reports to NIH, the NHLBI DSMB and other agencies, as required.